CORE--TISSUE

All of the projects within this Program, require the analysis of embryonic and/or adult murine tissues. The plan is to use the Tissue Core facilitates of the UCSD Cancer Center for routine histology, immunohistochemistry or in situ hybridization to analyse the various tissues obtained from the different projects. The facility is already set up and most of the major equipment is in place. Some methodologies will be modified or optimized specially for this program.